Multilevel Panel Study of Effects of Changes in Nursing on Health Equity and Patient Outcomes

Abstract
Maternal morbidity and mortality (MMM) rates in the U.S. are marked by racial disparities, long-
standing, and worsening. The hospital where a woman gives birth has been identified as a driver of these
poor outcomes, and the racial disparities therein. What it is about hospitals that leads to this variation has
not certain. Nurses provide most of the direct patient care for birthing women. In other patient
populations, nursing capital, the hospital resources which support nurses' work (e.g., staffing and the
work environment), is linked to morbidity and mortality and has a differential beneficial effect for Black
patients' outcomes, compared to White. Unlike a hospital's structural characteristics, like its teaching
status or patient acuity mix, nursing capital is modifiable and provides a potential intervention for
improving patient outcomes and disparities therein. These findings provide the foundation for the
proposed administrative supplement to NR014855 (“Multilevel Panel Study of Effects of Changes in
Nursing on Health Equity and Patient Outcomes”). The purpose of this supplement is to determine
whether there is an association between nursing capital and MMM, and whether there is a differentially
benefit for women from racial/ethnic minorities. Aim 1: To determine the association between a
hospital's nursing capital and the odds of MMM, especially for women from minoritized racial and ethnic
groups. We hypothesize that better nursing capital will be associated with overall decreased MMM and
that there will be a differential decrease in MMM for women from minoritized racial and ethnic groups.
Aim 2: To identify high-performing hospitals, where women from minoritized racial and ethnic groups
have the lowest rates of MMM, determine if there are hospitals that are high performing for particular
groups of women from minoritized groups. and develop evidence-based profiles of hospitals. Aim 3: To
determine the degree to which the nursing capital characteristics distinguish high from low-performing
hospitals and whether these characteristics vary for different groups of women. To accomplish these aims,
we propose a cross-sectional secondary analysis of the first wave of data from the parent study. Nurses
serve as informants, via a survey, about their hospital's organizational resources, including nursing
capital, quality, and safety. This data is combined with patient discharge abstracts and hospital data to
allow us to examine the association of hospital organizational resources with MMM for women from
racial/ethnic minority groups and to identify and describe high-performing hospitals. The overarching
aim of this work is to not only understand the association of nursing capital with MMM, or describe high-
performing hospitals, but to determine whether – as in other patient populations – nursing capital has the
potential to be a target for intervention to have a transformative effect on maternal outcomes and equity.

Public health relevance
Project Narrative Birth hospitalizations are the most common reason for hospital admission in the United States and our maternal morbidity and mortality outcomes, marked by long-standing racial disparities, are the worst of any industrialized nation, even as we spend more on maternity care and have numerous national, professional, and state initiatives attempting to move the needle on these poor outcomes. The hospital where a woman gives birth is a significant factor in her chance of experiencing morbidity or mortality, especially if she is from a racial/ethnic minority group, but we do not know what is about hospitals that leads to this relationship. Nurses provide most of the direct care when women come to the hospital to give birth and the resources which support their work explain hospital variation in morbidity and mortality in other patient populations and differentially benefits patients from racial minority groups; so, this project examines whether these hospital nursing resources are associated with maternal morbidity and mortality for women from minority racial/ethnic groups and might be a hospital-level intervention to move the needle on improving maternal morbidity and mortality.